Multiomics data integration methods to discover putative causal variants, genes and patient heterogeneity for Alzheimers disease

PROJECT SUMMARY
Despite the success of genome-wide association studies (GWAS) in identifying over 70 susceptibility loci for
Late-onset (LO) Alzheimer’s disease (AD), AD related disease and endophenotypes, it remains challenging to
pinpoint 1) which are truly causal AD variants; 2) the molecular processes that cause AD; and 3) how AD patients
are pathogenically different from each other. Emerging resources for the study of AD genetics, including
sequence, functional genomics and epigenomic data, provide unparalleled opportunity to investigate these
questions at different molecular levels. We propose a multiomics data integration project to characterizes AD
risk for both genetic variants and individual patients, by developing and applying a series of novel computational
approaches using Bayesian hierarchical modeling, variable selection and multivariate analysis, for analyses of
a wide range of existing and novel AD multiomics data. These methods are designed to integrate many genetic
factors — single nucleotide variants, brain tissue molecular traits such as gene expression, alternative splicing,
alternative polyadenylation, methylation, histone acylation and proteomics, and various functional annotations
for coding and non-coding regions — into a coherent framework for discovery of causal AD variants and genes,
and understand patient heterogeneity. Our goals are to 1) combine genetic association evidence from population
and family-based studies of diverse ancestry backgrounds; 2) incorporate functional information to infer putative
causal genetic variants; 3) identify novel molecular traits and QTLs for alternative polyadenylation and
differentially methylated regions in brain tissues; 4) dissect AD association signals using multiple molecular traits
across a comprehensive collection of brain tissues and relevant cell types; and 5) characterize AD patients’ risk
profiles using causal effects at different molecular levels across brain tissues. Our methods and bioinformatics
analyses will be engineered into a high-quality toolbox to also facilitate multiomics studies of other complex
diseases. We will develop fine-mapping methods for family and multi-ancestry data, integrated with thousands
of genomic functional annotations, to identify putative causal variants from whole-genome sequences. We will
develop a new method to generate alternative polyadenylation from RNA-seq data in brain tissues of AD patients
and controls, and fine-map its QTL. We will develop and apply new approaches to fine-map differentially
methylated regions in brains, to colocalize QTLs for dozens of molecular traits with AD, and to identify novel
gene-level associations using predicted molecular traits. Causal effects estimated at variants and gene levels
will be integrated to identify new AD gene-sets and pathways, and to characterize risk profiles for AD patients.
Causal variants and genes discovered from our project will provide insight for development of therapeutic drugs
targeting at specific cellar processes. The multiomics risk profiles built for AD patients will improve clinical trial
designs for AD drug development, paving the path to personalized therapeutics.

Public health relevance
PROJECT NARRATIVE The main objectives of this proposal are to create a coherent analytical framework tailored for integration of available and novel multiomics resources for brains and Alzheimer’s disease (AD), to identify causal variants and genes, and to characterize the genetic profile of AD patients at different molecular levels across brain tissues. By identifying novel causal effects attributable to molecular functions, our result will provide insight for development of therapeutic drugs specifically targeting at cellar process. The multiomics risk profile built for AD patients will improve clinical trial designs for AD drug development, paving the path to personalized therapeutics.